Center for Coordination of Analysis, Science, Enhancement, and Logistics (CASEL) in Tobacco Regulatory Science - Dissemination Core

PROJECT ABSTRACT – DISSEMINATION CORE
The Dissemination Core (DC) is the centralized communication hub for CASEL with the overarching goal of
fostering communication networks among FDA CTP scientists to encourage the uptake of best practices,
accelerate sharing of research findings, promote collaboration, and generate innovative research ideas. To
achieve this goal, we will implement a multifaceted approach to share and disseminate information within the
CTP research community that ensures ease of access and timely sharing of information and study results.
With our robust infrastructure, the Westat team is uniquely well-positioned to support communication within the
TRS research community and promote rapid dissemination of research findings to broad audiences. This Core
will house the centerpiece of our communication infrastructure, the TRS Knowledge Center website which
offers the community a wide range of TRS-specific resources and information. The DC will also continue the
successful CASEL Webinar Series and our bi-monthly Digest. The Core will be led by Dr. Cassandra Stanton,
who has served in this role on CASEL 1.0. Among the activities she will spearhead in the Core are initiatives
such as themed special journal issues that provided a high-impact forum for bringing together research in
priority topics from multiple-disciplinary teams across FDA CTP-funded grantees. Other modes of
dissemination will include concise summaries of recent research, workshops, scientific presentations, and
peer-reviewed journal articles. Through the work of this Core, existing resources will continually expand and
new systems employed to improve communication, tracking, and opportunities for rapid dissemination. As the
Center for Rapid Surveillance of Tobacco (CRST), TCORS, and other FDA CTP-funded grantees produce
research findings, CASEL will be ready to respond to support timely dissemination.